Solving the E. coli Class Ia Ribonucleotide Reductase a/b Interface Structure by Magnetic Resonance

Abstract Ribonucleotide reductase (RNR) catalyzes the conversion of ribonucleotides to deoxyribonucleotides, making it an essential enzyme to the life of all living organisms. As such, RNR has been a successful drug target for treating a wide range of cancers. However, only in a few cases such as the RNR from the Herpes virus has the α2β2 subunit interaction been utilized as a drug target. This is largely due to the lack of structural information on the RNR α2β2 subunit interface, despite the fact that the crystal structures of the individual α2 and β2 homodimers of the E. coli class Ia RNR have been known for more than two decades. The relative orientations at which α2 and β2 bind to form the complete α2β2 complex is generally understood, but there is little atomic resolution information on the subunit interaction, as many of the residues at the interface are unresolved in crystal structures. The objective of this work is to use the E. coli class Ia RNR as a model system to solve the structure of the α2β2 interface region by magnetic resonance spectroscopy. This structural information will be important for understanding the complicated proton-coupled electron transfer (PCET) processes that take place across the subunit interface, and lays a foundation for the development of drugs designed to inhibit PCET between α2 and β2 in class Ia RNRs. While α2β2 formation normally occurs only transiently during turnover, we demonstrate that a stable α2β2 complex can be trapped on a timescale and protein concentration sufficient for nuclear magnetic resonance (NMR) measurements. One subunit will be 13C-labeled, and the other 15N-labeled, allowing for an investigation of the intersubunit heteronuclear dipolar contacts unique to the interface region between α2 and β2. The sensitivity of the experiment will be enhanced by dynamic nuclear polarization experiments utilizing the biradical polarizing agent AMUPol (5-10 mM). 13C-15N contacts will be probed by the FS-REDOR and ZF-TEDOR pulse sequences. The final modeling of the α2β2 interface region will make use of molecular dynamics simulations of the available crystal structures constrained to previous cryo-electron microscopy data, previous pulsed electron paramagnetic resonance data, and the 13C-15N distance constraints determined in this work. Obtaining a structural model for the class Ia α2β2 subunit interface region of RNR is expected to aid in understanding the mechanism of proton-coupled electron transfer between α2 and β2, opening the door for drug development efforts targeting the RNR class Ia α2β2 subunit interaction.

Public health relevance
Project Narrative Ribonucleotide Reductase is an essential enzyme to the life of all living organisms, and is a drug target for a wide range of cancers. Solving the structure of the model E. coli class Ia subunit interface will facilitate drug development efforts to inhibit the enzyme activity.